BRinging the Diabetes Prevention Program to GEriatric Populations (BRIDGE)

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Although the CDC’s National Diabetes Prevention Program (DPP) is an evidence-based strategy to prevent diabetes,1,2 it was not designed to be inclusive of the varied linguistic needs of older adults. This limitation is a barrier to participation among those with limited English proficiency (LEP),3 who are more likely to be foreign-born.4 While the DPP is available in Spanish, studies show that Spanish-speaking participants are significantly less likely to attend sessions than their English-speaking counterparts,5,6 suggesting the program is not sufficiently tailored for this population.
A systematic review of Spanish-language diabetes prevention programs found that interventions are more effective when they adapted for literacy, incorporate culturally relevant foods and beliefs, and involve family members.6 However, these studies lacked a structured adaptation framework, limiting their reproducibility and scalability. Critically, older Spanish-speaking adults, have been largely overlooked in past adaptation efforts.
In this 18-month administrative supplement, we will leverage the existing BRIDGE (BRinging the Diabetes Prevention Program to GEriatric Populations) trial to systematically adapt the DPP for older Spanish-speaking adults. In Aim 1, we will conduct surveys to identify key behavioral determinants and risk factors in this population, guiding the linguistic and contextual adaptation of BRIDGE materials using the CDC’s Map of Adaptation Process (MAP). In Aim 2, we will assess the acceptability of these adaptations through clinician interviews and focus groups with Spanish-speaking older adults and their families, to inform a future feasibility pilot of the adapted intervention.

Public health relevance
This study addresses the urgent need to adapt the Diabetes Prevention Program (DPP) for older adults with limited English proficiency, a substantial and growing segment of the U.S. population. By systematically adapting the BRIDGE intervention for Spanish-speaking older adults, this project will provide a scalable model for linguistically tailored adaptations of evidence-based interventions that reduce diabetes and related metabolic morbidity and mortality. References 1. Reduction in the Incidence of Type 2 Diabetes with Lifestyle Intervention or Metformin. N Engl J Med. 2002;346(6):393-403. doi:10.1056/NEJMoa012512 2. Ali MK, Echouffo-Tcheugui J, Williamson DF. How effective were lifestyle interventions in real-world settings that were modeled on the Diabetes Prevention Program? Health Aff Proj Hope. 2012;31(1):67-75. doi:10.1377/hlthaff.2011.1009 3. Hall DL, Lattie EG, McCalla JR, Saab PG. Translation of the Diabetes Prevention Program to Ethnic Communities in the United States. J Immigr Minor Health. 2016;18(2):479-489. doi:10.1007/s10903-015-0209-x 4. Krogstad JM. English Proficiency on the Rise Among Latinos. Pew Research Center’s Hispanic Trends Project. May 12, 2015. Accessed December 19, 2022. https://www.pewresearch.org/hispanic/2015/05/12/english-proficiency-on-the-rise-among-latinos/ 5. Ritchie ND, Christoe-Frazier L, McFann KK, Havranek EP, Pereira RI. Effect of the National Diabetes Prevention Program on Weight Loss for English- and Spanish-Speaking Latinos. Am J Health Promot. 2018;32(3):812-815. doi:10.1177/0890117117698623 6. McCurley JL, Gutierrez AP, Gallo LC. Diabetes Prevention in U.S. Hispanic Adults: A Systematic Review of Culturally Tailored Interventions. Am J Prev Med. 2017;52(4):519-529. doi:10.1016/j.amepre.2016.10.028 7. Cowie CC, Casagrande SS, Menke A, et al., eds. Diabetes in America. 3rd ed. National Institute of Diabetes and Digestive and Kidney Diseases (US); 2018. Accessed September 11, 2023. http://www.ncbi.nlm.nih.gov/books/NBK567985/ 8. Beasley JM, Kirshner L, Wylie-Rosett J, Sevick MA, DeLuca L, Chodosh J. BRInging the Diabetes prevention program to GEriatric populations (BRIDGE): a feasibility study. Pilot Feasibility Stud. 2019;5(1):129. doi:10.1186/s40814-019-0513-7 9. Beasley JM, Johnston EA, Sevick MA, et al. Study protocol: BRInging the Diabetes prevention program to GEriatric Populations. Front Med. 2023;10:1144156. doi:10.3389/fmed.2023.1144156 10. Beasley JM, Johnston EA, Costea D, et al. Adapting the Diabetes Prevention Program for Older Adults: Descriptive Study. JMIR Form Res. 2023;7(1):e45004. doi:10.2196/45004 11. Haldar S, Pillai D, Published SA. Overview of Health Coverage and Care for Individuals with Limited English Proficiency (LEP). KFF. July 7, 2023. Accessed May 22, 2025. https://www.kff.org/racial-equity-and-health-policy/issue-brief/overview-of-health-coverage-and-care-for-individuals-with-limited-english-proficiency/ 12. State Language Data - NY. migrationpolicy.org. Accessed May 22, 2025. https://www.migrationpolicy.org/data/state-profiles/state/language/NY 13. McKleroy VS, Galbraith JS, Cummings B, et al. Adapting Evidence–Based Behavioral Interventions for New Settings and Target Populations. AIDS Educ Prev. 2006;18(supp):59-73. doi:10.1521/aeap.2006.18.supp.59 14. Wiltsey Stirman S, Baumann AA, Miller CJ. The FRAME: an expanded framework for reporting adaptations and modifications to evidence-based interventions. Implement Sci. 2019;14(1):58. doi:10.1186/s13012-019-0898-y